Epithelial Physiology and Cell Biology Workshop at the Telluride Science Res Ctr

DESCRIPTION (provided by applicant): By bringing together investigators with varied expertise in epithelial transport and cell signaling regulation of ion channels/transporters with clinicians focused on disease processes, the Epithelial Physiology and Cell Biology Workshop stimulates collaborations and catalyzes scientific progress , as has been exemplified by the successes of the previous meetings. This workshop is held annually (since 2004) in Telluride, Colorado with logistical meeting support provided by the Telluride Science Research Center. The cutting edge nature of the topics to be presented is reflected in the co-organizers, Drs. John Cuppoletti, My N. Helms, Thomas Kleyman, Peter Snyder, and a diverse range of speakers. Topics will include (but is not limited to) the role of free radicals in ion transport, molecular modeling of sodium channels based on the X-ray crystal structure of acid sensing ion channels, and the potential use of prostone based compounds to target chloride channels. Participation by junior researchers in this workshop will also be enhanced through a proposed Research Recognition Travel Award. PUBLIC HEALTH RELEVANCE: The annual Epithelial Physiology and Cell Biology Workshop, held in conjunction with the Telluride Science Research Center, sets new direction for scientific research. The Principal Investigator, together with Drs. Kleyman, Cuppoletti, and Snyder requests R13 funds that will defray the cost of travel for trainees who wish to attend this scientific workshop.

Public health relevance
The annual Epithelial Physiology and Cell Biology Workshop, held in conjunction with the Telluride Science Research Center, sets new direction for scientific research. The Principal Investigator, together with Drs. Kleyman, Cuppoletti, and Snyder requests R13 funds that will defray the cost of travel for trainees who wish to attend this scientific workshop.